Diabetes Research Center

CENTER OVERVIEW: Abstract
For 35 years, the NIDDK-funded Diabetes Research Center (DRC) at Joslin has successfully fostered break-
through discoveries in the field and rapidly translated advances into new strategies for prevention, treatment and
cure of diabetes and its complications. The DRC has catalyzed extensive collaborative basic and clinical diabetes
research at Joslin, Harvard Medical School (HMS) and other Massachusetts research institutions, bringing
together interdisciplinary expertise to address challenges in diabetes and related metabolic diseases. During the
past five years, publications by the Joslin DRC Research Base have led to paradigm-changing ideas on the
pathogenesis and treatment of various types of diabetes. Success in making these discoveries has been
accelerated by state-of-the-art technological resources and expertise of the Joslin DRC Biomedical Research
Cores and our program design that nimbly incorporates advances in the field. The Pilot & Feasibility Program
has successfully attracted and engaged early stage investigators who have stayed in the diabetes field and
competed successfully for NIH support. The Enrichment Program is the most extensive diabetes and metabolic
disease educational program for post-doctoral fellows, students and investigators in the Harvard Medical School
area, jointly supported by the Joslin DRC and institutional funding. In this competing renewal application, we
summarize growth of the Joslin Research Base, contributions by Joslin investigators to the diabetes field, and
the innovations that have been made in each component of our DRC program. We propose exciting new
directions for the Joslin DRC that will continue to accelerate scientific discoveries in fields of diabetes and
metabolism over the next five years.

Public health relevance
CENTER OVERVIEW: Project Narrative For the last 35 years, the Joslin Diabetes Research Center has provided critical infrastructure to catalyze groundbreaking diabetes research efforts at Joslin, at Harvard, and in the broader research community. Contributions of the Center’s Cores, Pilot & Feasibility Program, and Enrichment Program can be measured by their heavy use by 49 Joslin Research Base investigators and more than 40 outside investigators in the Boston area, and by the seminal publications that have benefitted from Center support. The Joslin Diabetes Center fosters collaborative, multidisciplinary approaches across the basic and translational spectrum to advance our understanding of diabetes and related metabolic disorders and to develop new treatments and preventive strategies for the disease and its complications.